Data Analysis Center for Somatic Mosaicism Across Human Tissues Network

Project Summary
The SMaHT Data Analysis Center (DAC) will participate in the Common Fund Data Ecosystems (CFDE)
project, which aims to broaden the use of the data generated in the Common Fund projects to accelerate
scientific discovery. The DAC will contribute data and knowledge gleaned from the data to the resources being
built by CFDE, work with other centers to standardize ontologies and metadata specifications, and make its
datasets FAIR (Findable, Accessible, Interoperable, and Reusable).

Public health relevance
Project Narrative The SMaHT Data Analysis Center (DAC) will contribute to the resources developed by Common Fund Data Ecosystems to increase the usefulness of its datasets.